Project 2: Alpha-Emitter Radioimmunotherapy-Based Allografting to Cure Acute Leukemia and Myelodysplastic Syndrome

PROJECT SUMMARY / ABSTRACT – Project 2
Allogeneic hematopoietic cell transplantation (HCT) cures some patients with acute leukemia and
myelodysplastic syndrome (MDS). Still, relapse rates remain high, and treatment-related toxicities further limit
the success with this strategy. Randomized trials showing that reduced relapse risks with higher doses of total
body irradiation (TBI) are offset by increased non-relapse mortality provided the impetus to employ radiolabeled
monoclonal antibodies (MAbs) to target radiation to hematopoietic tissues to improve the efficacy of allogeneic
HCT. Our early approaches used β-emitters, iodine-131 (131I) and yttrium-90, conjugated to our murine anti-
CD45 MAb BC8 to deliver targeted radiation in the HCT setting. However, the long path-length, long half-life,
and low energy of β-emitters limits the amount and precision of the delivered radiation, and γ?emissions of 131I
require patient isolation. The α-emitter astatine-211 (211At) is ideally suited to overcome these limitations as it
delivers a very high amount of radiation over a few cell diameters, thus minimizing toxicity to non-targeted cells.
The potent anti-tumor efficacy of α-particles and their target precision when conjugated to MAbs may avoid early
and late adverse effects, including secondary cancers, associated with other HCT conditioning agents. During
the current funding cycle, we successfully translated our preclinical findings with 211At-based radioimmuno-
therapy to 2 clinical trials with first-in-human infusions of BC8 coupled to 211At (211At-BC8-B10) to augment
minimal-intensity conditioning with fludarabine/low-dose TBI in adults with acute leukemia/MDS. To further
develop and refine this approach, we propose in Specific Aim 1 use of 211At-BC8-B10 as part of a minimal-
intensity conditioning for adults with advanced acute leukemia and high-risk MDS undergoing HLA-matched
or -haploidentical HCT to determine the maximal tolerated dose (MTD) and safety, and estimate its anti-tumor
efficacy. A subsequent trial will test 211At-BC8-B10 (at the MTD) in high-risk patients in morphologic remission.
A limitation of the use of a murine MAb such as BC8 is the significant infusion toxicities, along with potential to
cause a human anti-mouse antibody (HAMA) reaction, which limit its clinical use. Moreover, non-marrow toxicity
with 211At is primarily limited to hepatic injury which may, in part, be due to cells in the liver avidly taking up
conjugated MAbs via Fc receptors, resulting in liver-dominant off-target delivery of radiation. Therefore, in
Specific Aim 2, we propose to use humanized (“Trianni”) mice to develop fully human anti-human CD45 MAbs
and then preclinically characterize an improved 211At-labeled anti-CD45 MAb using Fc engineering to
minimize/abolish Fc receptor interactions, thus minimizing non-specific toxicities associated with the current MAb
form. Together, the overarching goal of Project 2 is to improve HCT outcomes for patients with advanced acute
leukemia and high-risk MDS by further advancing the use of the first-generation 211At-CD45 RIT in early phase
clinical trials while, in parallel, preclinically developing an optimized second-generation RIT reagent targeting
CD45 to limit off-target delivery and non-specific toxicities.

Public health relevance
PROJECT NARRATIVE– PROJECT 2 This project is focused on reducing the risk of relapse of malignancy in patients with advanced acute leukemia or myelodysplasia who have been treated with stem cell transplantation from healthy donors. We propose to accomplish this goal by using targeted radiation with an antibody to the cancer cell coupled to a short-lived radioactive isotope.